Pleiotropic pathways of extracellular calcium sensing

Summary
The human calcium-sensing receptor (CaSR) detects fluctuations in the circulating Ca2+ concentration and
maintains extracellular Ca2+ homeostasis by regulating parathyroid hormone secretion. In addition, the receptor
mediates a wide range of cellular processes unrelated to Ca2+ balance such as fetal development. Malfunction
of CaSR is associated with a vareity of Ca2+ homeostatic disorders including potentially life threatening neonatal
hypercalcaemic conditions. Abnormalities in the CaSR gene has also been implicated in other diseases including
cancer and Alzheimer’s disease. The functional diversity of the CaSR results from its ability to signal through all
four subtypes of G proteins, including Gq/11, Gi/o, Gs, and G12/13. We have used Cryo-electron microscopy (EM) to
solve the structures of active CaSR complexed with different G proteins. In this application, we will build upon
this structural data to explore how the CaSR achieves G protein selectivity and promiscuity using structure-based
functional studies. We will also assess the signaling effects of naturally occurring mutations in the receptor that
are linked to Ca2+ metabolic and other disorders. We will determine the impact of these mutations on cell surface
expression as well as activation of each of the four G protein families. In addition, we will explore the ability of
positive and negative allosteric modulators to normalize receptor signaling. Finally, we will initiate structural
studies to understand the mechanistic basis for naturally occurring mutations that differentially impact the various
G protein subtypes. Our work will elucidate the intracellular signaling mechanisms of the CaSR and map out the
functional roles of disease mutations. The information gathered from our studies will assist the design of
therapeutics targeting specific CaSR mutations and guide precision medicine efforts in the future.

Public health relevance
Project Narrative Human calcium-sensing receptor (CaSR) maintains extracellular Ca2+ homeostasis through regulation of parathyroid hormone secretion, and malfunction of CaSR is associated with calcium homeostatic disorders including life-threatening neonatal hypercalcaemic conditions. We are pursuing structure-based functional studies of the pleiotropic signaling pathways of the CaSR in order to elucidate the molecular determinants of its G protein selectivity and promiscuity. Our work will shed light on how naturally occurring mutations in the CaSR gene impact signaling to cause human diseases and initiate the exploration of precision pharmacotherapies targeting these mutations.